Administrative Core

2.0 Abstract: Administrative Core
The UMGCCC Administrative Core includes the Senior Leadership Team and Center Administration. The Senior
Leadership Team establishes the overall strategic direction and research mission for UMGCCC, and Center
Administration operationalizes this vision through interactions with internal and external stakeholders. Center
Administration provides infrastructure to support the Cancer Center Support Grant and to promote the cancer
research activities of its 225 members, with a particular focus on facilitating transdisciplinary and population-
based translational cancer research. The administration supports the director, senior leaders, program leaders,
shared services directors, and UMGCCC members in carrying out the Cancer Center mission through effective
strategic planning and evaluation, operational management, and centralized resources. UMGCCC
administration oversees a $36.1 million operating budget (FY2019) including clinical practice, grant and fiscal
management, and other administrative services for faculty and staff members; five established research
programs; one developing program; and seven shared services in addition to the (a) Training and Education and
(b) Community Outreach and Engagement components. The administrative staff is responsible for human
resources and administering partial salary support for over 150 full-time equivalents. Many of these reside in
Cancer Center–controlled space (213,705 gross square feet), which the administrative staff also manages.
Administrative responsibilities include management of Cancer Center membership, finances, personnel, grants
and contracts, clinical research agreements and trials, purchasing, philanthropy and providing administrative and
financial oversight to UMGCCC shared services; overseeing space utilization and common equipment;
facilitating recruitment efforts; managing Cancer Center meetings and membership; and coordinating and
facilitating pilot award programs and Cancer Center planning and evaluation activities (leadership and
programmatic meetings, seminars, annual symposia and retreats, and internal and external board meetings).
The administrative staff also support communication to the 225 UMGCCC members, the Community Advisory
Board, and the university as a whole as well as support legislative activities regarding the Cancer Center across
the State. The administrative team monitors and reports on member accomplishments, funding, and cancer-
related activity to the Research Council and other advisory groups as a part of the annual membership
evaluation. Conducting surveys and evaluation for planning are also functions of the central administrative staff.